Human Tissues Core

Summary
The goal of the Human Tissues Core is to provide expert cost-effective support and services to accelerate
human immunology research for P01 core users. This core will facilitate Institutional Review Board (IRB)
approval, collect, process and distribute fresh human tissue samples of spleen, lymph nodes, and tonsils for
P01 projects. The core will also collect serum from PBMC preparations, freeze unused cells, and facilitate
single cell recovery from cryostorage. Importantly, the tissue received by P01 core users will be de-identified
and the core will maintain a de-identified patient sample database. The Human Tissues Core C will leverage
existing resources and expertise at UMN, including ongoing collaborations with clinicians and surgeons to
streamline and expand services to provide fresh human immune tissue to the P01 projects.

Public health relevance
Narrative Our overall vision is to achieve a comprehensive understanding of tolerance mechanisms that operate under normal homeostasis, how they breakdown in human autoimmune diseases, and how they can be targeted therapeutically. These studies will require the use of human lymphoid tissues to evaluate immune cells from the spleen, lymph nodes, tonsils, and PBMC. The Human Tissues Core will support P01 projects to process and provide high quality human lymphoid tissues for research use.